Damage-Induced Activation of the TLR/mTOR/PPARg Axis Regulates the Immune Response After Burn and Inhalation Injury

ABSTRACT
There are multiple influences on morbidity and mortality in burn patients, with inhalation injury among the most
significant. Combined burn and inhalation injury (I+B) occurs in 5-30% of all burn patients and is characterized
by epithelial denudation, elevated leukocyte (neutrophil and macrophage) activity in the lung, with enhanced
local and systemic inflammation which when combined, lead to an increased morbidity and mortality of burn
patients including increased lung damage, graft-rejection and bacterial infections.
Although previous studies have explored immunological dysfunction during burn injury, no study has established
a mechanistic link between the immune dysfunction and the TLR/mTOR/PPARγ signaling axis after burn injury.
Similarly, there are currently no biomarkers, which can inform the clinical decision-making as to assess patients'
immune status, contributing to poor patient outcomes. We propose and have significant preliminary and
published data to support that burn-induced DAMP release induces toll-like receptor (TLR) signaling that drives
activation of the mTOR/PPARγ axis in neutrophils macrophages and pulmonary epithelial cells that promotes
inflammation and further tissue damage and thus a cycle of unresolved yet ineffective inflammation leading to
poor long-term patient outcomes. In addition, we have identified key aspects of burn-induced immune
dysfunction that can predict poor lung function, graft-rejection and susceptibility to bacterial infection after burn
and inhalation injury. Here we propose to evaluate the dynamics and mechanisms of TLR/mTOR/PPARγ induced
immune dysfunction post-burn injury. We propose to use our current knowledge to develop an index to rapidly
assess and objectively determine a burn patient's risk for poor outcomes to help inform decisions on clinical
care.
To this end, we will utilize innovative clinically applicable animal models of burn and burn-inhalation (B+I) injury,
coupled with novel technologies, to take directed and systems biology approaches to delineate mechanisms
associated with phenotypes observed. In addition, we will utilize clinical samples collected from burn and B+I
inpatients at the North Carolina Jaycee Burn Center to evaluate the translatability of mechanisms defined and
evaluate indices to predict poor patient outcomes. The significance of this proposal lies in its potential to move
the field forward in two key ways: 1) to define and delineate the kinetics of cellular and molecular mechanisms
underlying the immune dysfunction after burn injury, 2) to develop and validate a model to predict burn patients'
risk for poor outcomes based on immune dysfunction. Together the successful completion of this proposal will
inform the type and timing of therapeutic interventions to improve the morbidity and mortality of burn patients.

Public health relevance
PROJECT NARRATIVE Combined burn and inhalation injury occurs in 5-30% of all burn patients and is characterized by epithelial denudation, elevated leukocyte (neutrophil and macrophage) activity in the lung, with enhanced local and systemic inflammation which when combined, lead to an increased morbidity and mortality of burn patients including increased lung damage, graft-rejection and bacterial infections. This proposal will move the field forward in two key ways: 1) by defining and delineating the kinetics of cellular and molecular mechanisms underlying the immune dysfunction and 2) by developing and validating a model to predict burn patients' risk for poor outcomes based on immune dysfunction. The successful completion of this proposal will inform the type and timing of therapeutic interventions to improve the morbidity and mortality of burn patients.